UCSF Data Science Training to Advance Behavioral and Social Science Expertise for Health Research (DaTABASE) Program

Project Summary/Abstract
Behavioral and social science researchers are essential for advancing research on reducing health disparities.
The next generation of such researchers must be equipped with the most powerful, contemporary analytic
tools. Newly available data and methods have the potential to transform the questions asked, the research
designs used, and the statistical approaches applied to deepen our understanding of fundamental drivers of
health and increase our capacity to improve population health and reduce disparities. To take advantage of
these opportunities, we need researchers with interdisciplinary training that allows them to connect the
traditional behavioral and social science expertise with the rapidly evolving technical repertoire of
computational health scientists. The UCSF Data Science Training to Advance Behavioral and Social Science
Expertise for Health Research (DaTABASE) program braids training strands previously operating
independently within UCSF. Particular strengths of DaTABASE include: 1) Grounding in a rigorous,
interdisciplinary quantitative training program for a foundation in study designs and statistical analyses to
deliver actionable evidence on health; 2) Integration of advanced tools and multiple data streams, including:
UCSF’s groundbreaking HIPAA compliant (P3/P4 level data) LLM GPT-4 artificial intelligence (AI) platform
“Versa”, ‘omics, clinical (e.g., UC-wide, geolocated and longitudinal medical records, clickstream data from
UCSF’s unique clinical informatics infrastructure), digital (device-based data flows, social media data,
technology enabled cohorts), population (e.g., San Francisco Department of Public Health data linking health
and social services provided to homeless individuals or other vulnerable populations) and policy data sets
(e.g., local policies regulating cannabis retail outlets in California communities); 3) Training and research
activities organized around the elimination of health disparities. DaTABASE trainees will complete the rigorous
methodological training for a PhD in Epidemiology and Translational Science. Additional content training,
overseen by faculty in the UCSF Center for Health and Community, will provide theoretical frameworks and
disciplinary background for social and behavioral sciences. Additional quantitative methods training will be
delivered via the Bakar Computational Health Sciences Institute (BCHSI), Division of Clinical Informatics and
Digital Transformation, and the UC Berkeley/UCSF Joint Computational Precision Health PhD Program.
BCHSI emphasizes machine learning tools to mine data sources for novel insights and discovery, including
precision medicine and population health. This training initiative will prepare graduates to apply those analytic
tools to novel data sets for research on behavioral and social processes underlying health disparities. The
DaTABASE program will provide intensive mentoring from both content and methods experts. DaTABASE
alumni will be prepared to lead research addressing current and emerging public health challenges with
innovative computational and data science analytic approaches.

Public health relevance
Project Narrative This UCSF training grant (DaTABASE) will provide training in advanced data analytics to predoctoral researchers studying behavioral and social determinants of health. The program is a collaboration between the UCSF Department of Epidemiology and Biostatistics, Division of Clinical Informatics and Digital Transformation, UCBerkeley/UCSF Joint Computational Precision Health PhD Program, Bakar Computational Health Sciences Institute, and the Center for Health and Community. Unique strengths of the program include 1) a focus on health disparities; 2) exceptional clinical and population data sources; and 3) integrating advanced AI tools and machine learning methods into causal frameworks for actionable results.